Collaborating Proteins, Affected Histone Modifications and Targets of the ALL-1 P

Usecontinuationpages as neededto provide the required information in the format shown below. Start with Program Director(s)/Principal Investigator(s). List all other senior/key personnel in alphabetical order, last name first. Name eRA Commons User Name Organization Role on